Protein structure and dynamics in ultra-heterogeneous environments-Renewal

SUMMARY
Hydrogen bonding in crowded environments – impact on biomolecules: Biomolecular organization in vivo
is driven by crowding and heterogeneity. To date, protein structure, dynamics, and folding have been studied
almost exclusively in buffer solutions, yet cellular environments are highly complex. This project seeks to
characterize the driving forces behind protein structure and dynamics in environments that mimic the cytosol.
Specifically: 1. We will quantify the sequence and crowder-dependent impact on the solvation shell of
biomolecules, by mapping out the changes in solvent configurations and dynamics. 2. We will link changes in
the microscopic H-bond environment with bulk effects on protein structure and stability. 3. We will advance 2D
IR spectroscopic techniques to perform in-cell 2D IR measurements using labeled proteins in live mammalian
cells to measure H-bond dynamics in the cytosol. We will directly address the question of “what are the properties
of biological water?” which has been one of the key unresolved questions in the field.
Liquid-liquid phase separation (LLPS) – biocondensate structure, dynamics, and interactions: Despite
the popularity of biocondensates, the field has remained highly empirical. The residual secondary structure and
stability of biocondensates, specifically the balance between electrostatic interactions and hydrogen bonding is
not well understood. We seek to: 1. Investigate H-bond dynamics in partially disordered low-sequence-
complexity condensates. We will induce LLPS using fusing Cryprochrome-2, a light-activated oligomerization
protein to disordered domains (RGG) to generate “strong” (high physical crosslinking) and “weak” (low
crosslinking) condensates in situ by UV illumination. We will probe the role of local interactions by comparing 2D
IR measurements when LLPS is induced through crosslinking, crowding, or electrostatic interactions using RNA
oligos. 2. We will investigate residual secondary structure in intrinsically disordered domains. Specifically, does
LLPS promote folding. What is the role of LLPS in stabilizing secondary structure?
Rational design of biologics – protein-polymer interactions: Proteins represent a rapidly emerging approach
to therapeutics, though rapid degradation and low bioavailability pose a significant challenge. Polymer
conjugation (PEGylation) is used to stabilize the proteins and increase bioavailability. However, most of the
knowledge is empirical, as molecular models to explain how polymers interact with the protein surface are
lacking. We will address the following hypotheses: 1. PEG-protein interactions are highly dynamic without
specific “long-lived” contacts. Surface dehydration, or “water replacement” alters the backbone structure and
dynamics. 2. Polymers modify thermal denaturation pathways. 3. PEG allergies highlight the need to explore
alternative polymer architectures to avoid immunogenicity. Here, we will explore a series of alternative
compositions including linear and branched polymers.

Public health relevance
Public Health Relevance: The proposed project is relevant to translating protein studies to in vivo environments. Since protein (mis)folding, and aggregation are the underlying cause of numerous diseases and protein-nucleic acid interactions are essential for cellular function, these studies are essential to understanding the molecular mechanisms unpinning these phenomena.